Hazmat Disaster Preparedness Training Program

HDPT Project Summary/Abstract
The overall goals of WRUC’s Hazard Disaster Preparedness Training Program (HDPTP) are to:
1) Prepare workers to engage in disaster response and recovery efforts related to wildfires,
earthquakes, severe storms and floods, and other environmental disasters through strategic
outreach and education under a multi-sited California Disaster Hub, 2) Prevent and mitigate the
impact of climate disasters and industrial incidents on workers and residents of frontline and
fenceline communities through community-based emergency response training programs, 3)
Support the capacity of volunteer firefighters and emergency medical personnel to respond to
hazmat issues associated with wildfires and floods in rural communities in the Pacific Northwest.
These goals will be accomplished by UCLA LOSH, UC Berkeley LOHP and the University of
Washington through collaboration with worker, community, state and local responder groups in
each targeted area. Over the five-year grant period, we will train 1,595 workers and community
members per year in 101 English- and Spanish-language courses for a total of 4,490 contact
hours. WRUC will also participate in the NIEHS Worker Training Program Emergency Support
Activation Plan. These efforts will build and strengthen emergency response capacity and
institutionalize disaster preparedness efforts with these target groups in our region and
contribute to national disaster response initiatives.